Persistence and regression in lung premalignant lesions

Project Summary
Lung cancer is the leading cancer killer. Preventing lung cancer is vital to reducing the global cancer burden.
Pharmacological prevention is an appealing strategy because it reduces the burden of treating tumors and pro-
vides options for former smokers or lung cancer survivors who are highly motivated to minimize their lung can-
cer risk. Prevention agents can be targeted to high-risk patients with premalignant lesions (PMLs), but lung
PMLs often spontaneously progress and regress, making it difficult to avoid overtreatment. Recently, we identi-
fied molecular patterns that separate lung PMLs likely to persist to carcinoma from those likely to regress.
However, there is an urgent need to identify interception targets in these persistent PMLs. Identifying key
mechanisms in PML persistence targeted by prevention agents will empower a precision approach focused on
intercepting PMLs, which could significantly reduce tumor development high-risk patients. Our long-term goal
is to use targeted prevention agents to intercept lung tumor development in high-risk populations. The main
objective of this proposal is to identify interception targets in persistent lung PMLs. We identified a profile that
differentiates lung dysplasias likely to persist from those likely to regress. This profile implicates loss of cell cy-
cle control, altered adherens junction components, decreased M1 macrophages, and increased regulatory T-
cells in dysplasia persistence and includes a gene expression panel for persistence. We chose Iloprost and
PD-1 inhibition as valuable tools for investigating persistence pathways in lung PMLs, based on their efficacy in
clinical trials and known targeting of epithelial or immune cells, both components of the persistence profile. We
hypothesize that persistence pathways can be targeted to intercept the lung PMLs most likely to progress to
carcinomas, and that changes in the persistence profile correlate with response to prevention agents. We will
use an innovative and human-relevant reverse translational approach to test this hypothesis in the following
specific aims: 1) Identify interception targets in the persistence profile in clinical trial biopsies, 2) Determine ef-
fects of prevention agents on persistence pathways in vivo, 3) Identify the mechanistic targets in persistence
pathways for prevention agent activity. After successful completion of this work, the expected outcome is
demonstration that prevention agents targets persistence mechanisms in lung PMLs at risk of progressing to
carcinoma. This project is innovative because it uses state-of-the-art assays and shifts the prevention research
paradigm away from bench to beside translation, instead using clinical data to inform human-relevant mecha-
nistic studies at the bench and cage. Our results will provide a strong basis for further development of precision
application approaches for medical prevention, which would significantly impact populations at high risk of lung
cancer by targeting the patients most at risk of progressing to invasive carcinoma. This project will advance
lung cancer prevention research and address a critical need of the NCI Division of Cancer Prevention.

Public health relevance
Project Narrative Pharmacologic prevention of lung cancer is an appealing strategy in high-risk populations because it reduces the eventual burden of treating tumors and provides options for former smokers or lung cancer survivors who are highly motivated to minimize their lung cancer risk. This project will use cells, mice, and human samples to investigate premalignant changes in the lung and to explore how medicines could reverse these changes and intercept tumor development. This research aims to reduce lung cancer mortality by improving understanding of premalignant lung cancer biology and advancing precision prevention agents, which addresses critical needs of the NCI Division of Cancer Prevention.